A Bruker Console Upgrade for the OHSU Advanced Imaging Research Center 11.7T MRI

Project Summary/Abstract
The Oregon Health & Science University (OHSU) Advanced Imaging Research Center (AIRC) was established
in 2003 to provide access to state-of- the-art instruments and expert technical support in magnetic resonance
science to the OHSU research community. The Center now supports four high-end research-dedicated MRI
instruments that includes two whole-body 3 Tesla(T) Siemens Prisma scanners, a large-bore (90cm) 7T
Siemens Magnetom, and a 31 cm bore 11.7T Bruker small animal instrument. Three of the instruments are
located on the main OHSU campus located on Marquam Hill, overlooking downtown Portland, and one of the
3T MRI instruments is located at a satellite AIRC facility on the campus of the Oregon National Primate
Research Center (ONPRC). Each of these instruments has substantial capability to generate large amounts of
data, allows investigators to work seamlessly between small/large animal models of disease and clinical
studies and, in doing so, advance our understanding of the root causes of human disease. Ultimately, we
expect the magnetic resonance data generated by the OHSU community to play a pivotal role in the
development of new methods of prevention, early diagnosis and intervention for many disease states.
However, the image quality, temporal resolution, scanning environment, and maintenance concerns necessary
to remain productive in this area requires that our 16 year old 11.7T small animal MRI instrument be upgraded.
The subject of this application is to request funds for an upgrade of our current Bruker AVANCE II to a Bruker a
Bruker AVANCE NEO console. Our current instrument has been in operation since 2006 and supports more
than 20 investigators, many junior faculty with projects funded through federal agencies, and plans for a large
number of new studies as we move forward. The proposed upgrade will provide much needed improvements
in gradient performance, data acquisition speed, temporal stability, improved workflow, and post-processing
capabilities (data access, image reconstruction, calculation) and reduced downtime; capabilities that will
substantially benefit on-going and newly proposed studies.

Public health relevance
Project Narrative Funds are requested to upgrade a heavily used 16 year-old 11.7T small animal MRI instrument at Oregon Health & Science University's Advanced Imaging Research Center. This system is used by a twelve NIH and other federally funded investigators including many junior investigators to improve public health through the study of many animal models of human disease including: Alzheimer's disease, vascular disease, neuroregenerative research, substance abuse, brain cancer, pancreatic cancer, diabetes, and other disorders. The requested upgrade will accelerate scientific discovery for a growing community of scientists conducting innovative magnetic resonance research at OHSU.